Impact of the gut microbiome on B cell-mediated neuroinflammation in cerebral amyloid angiopathy

PROJECT SUMMARY
Recent studies exploring the mechanisms that facilitate the crosstalk between the brain and the gut microbiota
have demonstrated the importance of the “microbiota-gut-brain axis” (MGBA) in aging and age-related
neurodegenerative disorders. The MGBA plays key regulatory roles in aging and in the development and
progression of neurological diseases such as Alzheimer’s disease (AD) and cerebral amyloid angiopathy (CAA).
CAA is an age-related small vessel disease characterized by amyloid-beta (Aβ) accumulation in the basement
membrane of the brain vasculature. CAA is a primary contributor to the pathophysiology of recurrent intracerebral
hemorrhages, stroke, and progressive cognitive decline in the elderly.
Several recent studies have highlighted the detrimental role of lymphocytes in the context of AD and related
dementias. Regarding the specific role of B cells, prior studies have shown that depletion of B cells reduced Aβ
plaque burden, disease-associated microglia, and reversed cognitive and memory impairment in murine models.
B cells are multifunctional cells that are integral to host adaptive and humoral immunity. They mount antigen-
specific responses to clear pathogens via phagocytosis and antibody dependent cellular cytotoxicity. Our
preliminary studies revealed that symptomatic Tg-SwDI mice (CAA mice; 10-13 months) have 1) increased
CD19+ cells (B cells) in immune compartments of the central nervous system including the brain and skull and
2) dysbiotic bacterial compositions in the gut, compared with pre-symptomatic CAA mice (2 months) and age-
matched wild-type (WT) mice (10-13 months). Surprisingly, fecal microbiota transplantation (FMT) from
symptomatic CAA mice increased the presence of brain B cells in recipient young naïve WT mice. These mice
developed significant cognitive deficits when compared to young WT mice that received FMT from pre-
symptomatic CAA mice. Based on our findings, we propose to test the following hypotheses using a mouse
model of CAA: (1) CAA induces B cell-driven inflammation in the brain; (2) CAA-induced gut dysbiosis can
promote B cell-mediated neuroinflammation which contributes to the pathogenesis and progression of CAA; and
(3) targeting B cells can limit CAA pathophysiology.
Successful completion of our study will discover new mechanisms that may allow us to target brain B cells to
improve outcome in CAA. These studies will also serve as an important initial step in understanding the
bidirectional role of brain-gut axis in the development of age-related chronic neuroinflammatory conditions such
as CAA and AD.

Public health relevance
PROJECT NARRATIVE Cerebral amyloid angiopathy (CAA) is characterized by amyloid-beta (Aβ) accumulation in the vasculature of the brain that contributes to both Alzheimer’s disease and stroke and leads to chronic cognitive impairment and dementia. This project will examine if B cells are involved in neuroinflammation and Aβ pathology in CAA, and whether CAA-induced gut dysbiosis contributes to this B cell-mediated neuroinflammation. We will use state-of- the-art approaches including flow cytometry, spatial gene expression profiling and single-cell RNA sequencing to explore the novel microbiota-gut-brain axis in CAA.